Cannabidiol and buprenorphine: A poly-pharmacy approach to treat opioid use disorder

PROJECT SUMMARY
Each year, millions of Americans are diagnosed with opioid use disorder (OUD), and opioid overdose claims
over 80,000 lives. These staggering statistics persist despite the availability of buprenorphine, a highly effective
and the most widely prescribed OUD medication. However, as many as half of OUD patients maintained on
buprenorphine discontinue treatment within one year, in part because of underdosing. Particularly in patients
who used fentanyl, doses of buprenorphine larger than the dose recommended by the Food and Drug
Administration (FDA) can improve treatment retention; however, large doses can have adverse effects including
ventilatory depression and sedation. Moreover, physical dependence can develop from long-term maintenance
with large doses, therefore abrupt discontinuation can result in withdrawal which increases the risk of relapse.
Outcomes for the thousands of OUD patients prescribed buprenorphine could be significantly improved by
identifying a safe and effective adjuvant treatment that enhances the therapeutic effects of smaller doses of
buprenorphine without increasing the adverse effects observed with larger doses of buprenorphine. The
cannabinoid cannabidiol (CBD) has been touted as a potential adjuvant as it can attenuate cue-induced craving
in OUD patients maintained on buprenorphine. CBD is approved by the Food and Drug Administration for
epileptic seizures, and is non-psychoactive, non-addictive and has a wide therapeutic window and desirable
safety profile. The overarching goal of the proposed study is to evaluate CBD as a potential adjuvant to
buprenorphine. Aim 1 will use a fentanyl-food choice procedure with male and female rhesus macaques to
examine how chronically administered CBD modifies the effects of buprenorphine on fentanyl choice. In Aim 2,
the safety of chronically co-administering CBD and buprenorphine will be characterized by measuring their
effects on oxygen saturation, heart rate and activity. With the use of NHPs, a predictive drug-choice procedure
and by measuring clinically relevant physiological effects, the proposed studies are translational and have a high
degree of predictive validity. Because CBD and buprenorphine are FDA-approved medications these findings
could be particularly impactful as they could be rapidly translated to clinical trials. Taken together, these studies
could identify CBD as a non-psychoactive, non-addictive and safe adjuvant to buprenorphine that improves its
effectiveness, and, ultimately, outcomes for the thousands of OUD patients maintained on buprenorphine.
Importantly, the rigorous research training and many professional development activities proposed in this
application (e.g., writing grants and manuscripts, attending and presenting at scientific meetings) will enhance
the applicant’s research repertoire to encompass new scientific knowledge, skills and experience. Achieving the
training goals described herein will contribute significantly to her success in transitioning from a postdoctoral
fellow to an independent investigator dedicated to studying substance use disorders.

Public health relevance
PROJECT NARRATIVE Millions of Americans are diagnosed annually with an opioid use disorder and buprenorphine is the most widely prescribed medication assisted treatment. Although larger buprenorphine doses can improve treatment outcome, they can also produce adverse physiological effects, physical dependence, and discontinuation can result in withdrawal and increase the risk of relapse. The present study will evaluate the potential of cannabidiol as a safe, non-psychoactive, and non-addictive adjuvant treatment that enhances the effectiveness of smaller doses of buprenorphine, which could ultimately improve treatment outcomes for thousands of opioid use disorder patients.